Feasibility of a study to determine the incidence, spectrum, course and outcome of Pediatric Acute-Onset Neuropsychiatric Syndrome (PANS) in a diverse group of children

PROJECT SUMMARY/ABSTRACT
The goal of this study is to determine the feasibility of a proposal to determine the incidence, breadth of clinical
manifestations, course and outcome of Pediatric Acute-Onset Neuropsychiatric Syndrome (PANS) and
Pediatric Autoimmune Neuropsychiatric Disorder Associated with group A Streptococcus (PANDAS) in a
geographically and economically diverse population of children in the US. PANS is a relatively newly described
clinical problem characterized by the acute onset of either obsessive-compulsive disorder (OCD) or food
restriction (or both) plus two of 7 other neuropsychiatric/behavioral issues in children. PANS may be triggered
by infectious or non-infectious stimuli. When Group A streptococcus (GAS) is the instigator event, it is referred
to as PANDAS. The two cardinal features of PANDAS are tics and OCD. Intrinsic to both syndromes is the
extremely acute onset of symptoms. Knowledge of the incidence, breadth, course and outcome of
PANS/PANDAS has been hampered by the absence of both a biomarker and a registry. Most studies of
clinical presentation have been retrospective and emerged from research/referral centers which provide an
unavoidably skewed picture of the most severe cases which are catastrophic but may not be representative.
In Specific Aim 1a we will demonstrate the feasibility of the prospective identification, enrollment and clinical
description of children with PANS and PANDAS in geographically distinct populations of children in the US in
order to determine the incidence, spectrum and course of these disorders. To accomplish this aim we will
identify 2 different health systems which include a primary care population of children with an electronic health
record (EHR) that is comprehensive. Using a combination of a ‘best practice alert’ and a tailored algorithm,
pertinent EHRs will be reviewed every weekday. Applying stringent clinical criteria, we will enroll consecutive
children with new and abrupt onset of tics, OCD or food restriction who fulfill the definitions for PANDAS/PANS
and follow them. We will successfully enroll 85% of the children meeting criteria. In Specific Aim 1b we will
demonstrate that GAS is an instigator event in at least 65% of cases of PANS. In Specific Aim 2 we will
determine the feasibility of studying the course and outcome of children with PANS/PANDAS enrolled
prospectively. Children identified in Aim 1 will be evaluated at baseline and every 6 months with the Child-Yale
Brown Obsessive Compulsive scale (CY-BOC) if the child has OCD, the Yale Global Tic Severity Scale (YG-
TSS) if the child has tics, the Clinical Global Impairment score (CGIS) and the Child Global Assessment Scale
(CGAS). The compilation of these scales will allow classification of at least 85% of children at outcome as being
in remission, or having mild, moderate or severe disease. This rigorous, prospective, observational study will
demonstrate the feasibility of this approach in preparation for a larger multicentered study with more prolonged
follow-up. A comprehensive understanding of the entire scope of illness will facilitate appropriate allocation of
therapeutic resources and set the stage for randomized clinical trials to assess treatment modalities.

Public health relevance
PROJECT NARRATIVE The goal of this study is to provide a proof-of-concept of the feasibility of a proposal to determine the incidence, spectrum, course and outcome of Pediatric Acute onset Neuropsychiatric Syndrome (PANS) and Pediatric Autoimmune Neuropsychiatric Disorder Associated with group A Streptococcus (PANDAS) in a geographically and economically diverse population of children in the US. Children will be identified in near real-time via electronic medical records and followed prospectively to describe the breadth of clinical manifestations, course and ultimate outcome. After feasibility is demonstrated we will embark on a large multicentered geographically representative study.